An Integrative Longitudinal Analysis of Neural Rhythms in Early Development

PROJECT SUMMARY / ABSTRACT
Our investigation is a developmental cognitive neuroscience examination of neural processing during early
development. Brain electrical activity consists of multiple, co-occurring oscillatory rhythms that underlie functions
critical to simple and complex brain processes. Spatiotemporal characteristics, functional properties, neural
generators, and psychological correlates characterize these individual oscillatory rhythms in adult research.
These neural signatures are essential for our understanding of brain processes involved in early self-regulatory
cognitive and affective processes. Methods for examining brain systems and their oscillatory signals in infants
and children, however, have long been non-systematic, lacking the level of standardization, sophistication, and
scientific rigor seen in the adult research literature. There is a need for research that characterizes early brain
functioning in typically developing infants and young children because it allows scientists to distinguish individual
differences in development from at-risk trajectories. Our goal is to provide the first comprehensive and
systematic analysis of longitudinal changes in EEG rhythms across infancy and early childhood. Our systematic
examination of multiple oscillatory rhythms (delta, theta, alpha/mu, beta) will enhance understanding of their
frequency signatures, spatial topographies, and functional properties, all within a developmental time course.
We will address three research aims. 1) We will identify and compare developmentally appropriate techniques
of characterizing neural oscillatory rhythms. 2) We will characterize ontogenetic changes in neural oscillatory
rhythms and their interactions. 3) We will determine whether individual differences in neural oscillation
parameters and their developmental trajectories are related to developmental outcomes.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Electrical activity in the brain consists of multiple co-occurring rhythms that underlie communication and transmission of information between brain networks during both simple and complex processes. Because brain activity during infancy and early childhood is critical to self-regulation, knowledge of early developing brain electrical patterns is critical for understanding how different brain electrical rhythms influence multiple developmental outcomes.